The Physiology of Store-Operated Channels in the Nervous System

Project Summary
Ca2+ signaling mediates many essential roles in the brain including neurotransmitter release, synaptic
plasticity, and gene transcription. Neurons and glia have an extensive Ca2+ signaling toolkit that includes
many types of ion channels and Ca2+ release pathways which can be mixed and matched to create
signals with widely different spatial and temporal properties. One of the newest - and least understood
- members of this toolkit in the brain is store-operated calcium entry (SOCE). SOCE is mediated by the
opening of Orai channels (Orai1-3), which are activated by the endoplasmic reticulum Ca2+ sensors,
STIM1 and STIM2. In immune cells where SOCE was first discovered, the pathway mediates critical
functions including gene expression and cytokine release, and aberrant Orai/STIM function is implicated
in the etiology of several diseases including immunodeficiency, inflammation, and myopathy. However,
in the brain where multiple isoforms of Orai and STIM are expressed, the molecular mechanisms and
physiological functions of SOCE remain very poorly understood. Previous work on the molecular
choreography of SOCE has revealed that Orai channel opening is triggered by a unique inside-out
mechanism where store depletion activates the ER Ca2+ sensors STIM1 and STIM2 which then
translocate to ER-plasma membrane contact sites to directly gate Orai1 channels. Our previous
mechanistic work has established a strong framework for understanding the gating mechanisms of Orai
channels, and using conditional Orai1 and STIM1 knockout mice, we have now begun to discover vital
roles for Orai channels in effector functions in the brain such as NFAT-mediated gene expression,
synaptic plasticity, and memory. We have learnt that SOCE in neurons exhibits unique specializations,
including rapid activation and unusual Ca2+ dependencies whose basis cannot be readily explained
easily from existing activation models. In this application, we aim to build an integrated view of the
SOCE mechanism in the nervous system, its micro and macro architecture, regulation, and gating, and
elucidate how neurotransmitter and receptor signaling through SOCE impacts fundamental processes
of synaptic communication, metabolism, learning, and cognition. To address this goal, we will use a full
range of approaches from electrophysiology, structural analysis, and molecular dynamics simulations
to behavioral analysis of cognition, depression, and disease to gain an unprecedented view of the SOCE
mechanism in the brain. These studies will address the role of a poorly understood Ca2+ entry pathway
in the nervous system with immense relevance for a range of functions from cognition to pain, and
ultimately facilitate efforts to target Orai channels for drug discovery for neurological diseases.

Public health relevance
Narrative The goal of this project is to understand the molecular mechanisms and physiological roles of store-operated calcium channels for Ca2+ signaling in neurons and astrocytes, and examine implications for brain pathologies including inflammation-induced depression and neuropathic pain. Findings from these studies will provide new mechanistic insights into Ca2+ signaling pathways controlling neuronal and astrocyte function, and could in the long run, yield a new therapeutic target for brain diseases.